Physically Realistic Virtual Surgery

Physically Realistic Virtual Surgery
Abstract
While virtual reality (VR)-based surgical simulation technology is being developed to improve laparoscopic
surgical training outside the operating room (OR), existing simulators focus mostly on technical skills (TS) of
hand-eye coordination for isolated tasks and seldom on non-technical skills (NTS) associated with both
cognitive skills of decision making, as well as interpersonal skills of communication, team-work and conflict
resolution. To enable VR-based surgical simulators to also train for cognitive skills, in the previous grant period
we successfully developed the next generation (Gen2) of laparoscopic surgical simulators that immerse the
trainee in a virtual OR using a head-mounted display (HMD) system, and introduce distractions, interruptions
and other stressors to capture the high-stress environment of the real OR. However, to the best of our
knowledge, there exists no VR-based simulator for training interpersonal skills needed for the
multidisciplinary integration of OR teams, which consist of surgeons, anesthesiologists, and
perioperative nurses. Following the significant reduction of adverse events in other disciplines, such as
aviation, by the introduction of mandatory simulation-based team training (e.g., crew resource
management), the National Surgical Skills Curriculum developed by the American College of Surgeons
(ACS) and Association of Program Directors in Surgery (APDS) has prescribed ten team-based training
modules to be performed in a simulation facility (e.g., an OR endosuite) with scenario-based training on high-
fidelity manikin simulators. However, such facility-based team training is extremely expensive and
cumbersome, requires dedicated facility and faculty time, and entails significant planning and schedule
coordination between trainees, technicians, and faculty. To overcome the challenges of facility-based OR
team training, the goal of this project is to extend the immersive VR technology (Gen2) developed as part
of our prior grant for a single user to the entire OR team, and harness recent advances in cloud computing,
mobile device-based VR and artificial intelligence and machine learning to design, develop and
evaluate a Virtual Operating Room Team Experience (VORTeX) simulation system. The VORTeX will allow
the OR team to train together in a distributed fashion (i.e., not co-located in the same room or simulation
facility) wearing mobile device-based HMD systems to develop further their NTS based on computer-generated
simulation scenarios replacing the physical ones. Evaluation of the simulation scenarios will be performed
asynchronously by a team of experts based on post-action replays. We will implement the VORTeX for a
laparoscopic cholecystectomy crisis scenario, developed and validated by our Co-I Dr. Dan Jones at BIDMC
and adopted as one of the team training modules of the ACS/APDS national surgical skills curriculum. We
hypothesize that the VORTeX will be at least as good as or better than traditional facility-based
simulation in providing non-technical skills training to OR teams.

Public health relevance
Project Narrative: The goal of this research is to develop and validate a comprehensive computer-based technology that will allow surgical trainees to practice their surgical skills on computer-based models. Surgical procedures and techniques, learnt and perfected in this risk-free manner before application to patients, will translate to fewer operating room errors, reduced patient morbidity and improved patient outcomes resulting in faster healing, shorter hospital stay and reduced post surgical complications and treatment costs.